Efficiency of evidence accumulation (EEA) as a higher-order, computationally defined RDoc construct

PROJECT SUMMARY/ABSTRACT
Cognitive constructs relevant to self-regulation, including cognitive control, attention, and working memory, are
a prominent focus of the Research Domain Criteria (RDoC) initiative to characterize dimensions of individual
variation that convey risk for mental disorders. However, many of these constructs are limited by their vague
definitions, ambiguous links to neurobiology, and evidence that putative measures of such constructs have
weak psychometric properties, including poor reliability and an incoherent factor structure. Further, consistent
findings that people with multiple psychiatric disorders tend to display non-specific cognitive deficits that span
this array of constructs suggest that cognitive aberrations associated with psychopathology may be better-
explained by a higher-order factor than by discrete functions. We propose to evaluate whether efficiency of
evidence accumulation (EEA)—a cognitive construct that has been well-characterized in computational
modeling and neurophysiological research but has yet to be integrated with RDoC—can overcome many of
these limitations by operating as a higher-order factor within the RDoC matrix. EEA is a core mechanism of
evidence accumulation models (EAMs)—a predominant mathematical framework for explaining cognitive
performance— that has a precise computational definition across both psychological and neurophysiological
levels of analysis, clear biological plausibility, and strong psychometric properties. Prior work has established
EEA as a reliable factor that accounts for individual differences in performance across a wide variety of
cognitive tasks—from simple decisions to complex cognitive control and working memory paradigms—and is
impaired in multiple disorders linked to self-regulatory difficulties. We posit that EEA represents a higher-order
factor that accounts for a substantial proportion of the variation across cognitive domains in the RDoC matrix
and that weak EEA conveys risk for multiple psychopathologies, potentially by impairing decision making
across contexts. EEA has yet to be integrated with RDoC and, although trait (between-subjects) variation in
EEA is linked to psychopathology, the correlates of state (within-subjects) variation in EEA across real-world
contexts are unknown. We propose to evaluate EEA’s role as a candidate higher-order factor in the RDoC
framework and set the stage for a larger program of computationally rigorous research on EEA as a bridge
between neurobiological mechanisms and real-world behavior by completing the following aims: 1) define the
structure and boundaries of trait EEA as a higher-order cognitive domain in the RDoC matrix, 2)
develop and pilot tools for daily assessment of state EEA and its relations with real-world fluctuations
in contextual factors and behavior. This project has the potential to refine RDoC in a way that that better
represents cognitive risk factors for psychopathology (i.e., task-general and transdiagnostic associations
between cognition and psychopathology constructs) and allows it to leverage key benefits of well-established
computational models to increase the precision and biological plausibility of RDoC constructs and measures.

Public health relevance
PROJECT NARRATIVE The Research Domain Criteria (RDoC) initiative is a prominent research effort to identify differences in brain functions that place people at risk for mental disorders, but many of these functions are difficult to define and measure, have ambiguous links to neurobiology, and do not have selective relationships with specific disorders. The proposed project seeks to evaluate whether efficiency of evidence accumulation (EEA), a precisely defined brain process that has been well-characterized in computational modeling and neurophysiological research, can move the RDoC initiative forward by improving measurement of complex brain functioning and better explaining its relationship with a wide array of mental disorders. Insights from this project could be used to accelerate neuroscience research into the causes and treatments of psychological disorders and refine diagnostic criteria in mental health care.